A PROGNOSTIC ASSAY FOR METASTATIC CLEAR CELL RENAL CELL CARCINOMA

ABSTRACT
An estimated 79,000 Americans were diagnosed with renal carcinoma in 2022 and approximately 13,920
died, primarily as a result of metastasis. First line treatment involves localized surgical removal of the primary
tumor as systemic therapies are generally reserved for metastatic dissemination. While ccRCC surveillance
protocols have improved over recent years, aggressive management with immunomodulators and
chemotherapeutic agents is generally withheld until after significant recurrence or metastasis is identified;
although this is generally too late to effectively manage or deter advanced cancerous spread, which is reflected
by a post-metastasis 5-year survival rate of just 14%. The goal of this Phase II SBIR is to further address the
absence of quantifiable targeted metabolite biomarkers in ccRCC tissues that accurately and specifically
predict early disease progression to metastasis. Ultimately, we seek to identify those patients that express
aggressive subtype(s) of renal cancer that would benefit from earlier initiation of systemic therapy. Likewise,
evaluation of this newly identified 12-marker panel can determine those patients who will have metastatic
disease with 100% specificity and may confidently choose a more conservative management approach.
There is a clear unmet clinical need to stratify aggressive cancer subpopulations within certain
malignancies like ccRCC, yet, there are currently no prognostic or diagnostic tests on the market that predict
metastasis. In pilot studies, LAGRANGE SCIENTIFIC was able to overcome major problems that encumbered
previous metabolic studies, such as primary tumor tissue heterogeneity and day-to-day, as well as lab-to-lab,
MS variability. Additionally, further refinement of our pre-analytical and post-acquisition normalization
techniques, in addition to metabolite quantification methods, have demonstrated stronger accuracy and higher
robustness. Indeed, we have identified in our feasibility studies a panel of metabolite markers that are 100%
specific and 83% sensitive – with 100% PPV and 94% NPV – in identifying ccRCC patients that progress to
metastasis at the time of primary ccRCC tumor resection (1.7 - 4.6 years sooner than standard of care). In
order to help validate our prototype, we will utilize the ccRCC biorepositories from the Eastern Virginia Medical
School PROBE cohort, Ontario Institute for Cancer Research Tumor Bank, University of Florida, University of
Virginia, and UT Health San Antonio; which account for over 894 renal tumors with associated patient data and
follow-up. We will begin prospective tissue collection at the University of Florida, Jacksonville, and continue
collection at UT Health San Antonio, which are accompanied by updated databases that further allow us to
identify patients who underwent a primary ccRCC tumor and metastasized (Cases) vs patients who did not
progress to metastasis (Controls). Paired “Normal” adjacent tissue will be obtained when feasible. For this
Phase II R&D, we will expand upon our extremely successful results from our pilot proof-of-concept studies
and further develop our prototype and commercialization strategies.

Public health relevance
PROJECT NARRATIVE The aggressive and unpredictable nature of metastatic clear cell renal cell carcinoma (ccRCC) is reflected by high rates of morbidity and mortality. While drastic improvements to post-surgical surveillance protocols have been made over recent years, early identification of progression from primary tumor to a disseminated metastatic disease state remains a difficult challenge for physicians and frequently results in detrimental delays of therapeutic intervention. LAGRANGE SCIENTIFIC is developing an innovative technology that accurately and specifically identifies which patients at the time of primary tumor resection will experience a disseminated ccRCC metastasis, and with Phase II support, will mature this highly accurate prognostic test for later progression to metastasis into a regulatory-approved laboratory testing service.